Blocking granzyme-mediated immune suppression to enhance HIV vaccine efficacy

SUMMARY
Immunization represents one of the most successful public health interventions in human history, preventing
more than 2 million deaths each year. Vaccine success depends on a variable combination of antibodies that
can neutralize the invading pathogen and virus-specific T cells that kill infected targets. However, the induction
of neutralizing antibodies and antiviral T cells that are sufficiently functional and broadly targeted to thwart a
highly mutable pathogen like HIV has proven exceptionally difficult in both humans and animal models. Thus,
there is currently no efficacious vaccine to prevent the nearly 5,000 new infections with HIV that occur each day.
This shortcoming in vaccine success is likely due to intrinsic immune regulatory mechanisms that limit the
quantity and quality of HIV-specific immune responses. Development of translational means to overcome these
immunological roadblocks holds great promise for advancement of next-generation vaccines to prevent HIV
infection and improve global health.
Our research focuses on the remarkable capacity of natural killer (NK) cells to suppress the magnitude and
quality of antiviral T and B cell responses triggered after immunization. NK cells impair the generation of
protective neutralizing antibody responses by inhibiting follicular helper T cell responses and restricting affinity
maturation of antibodies within germinal centers. This NK-cell immunosuppression also limits the quantity and
quality of antiviral memory T cell responses. NK cells achieve this suppressive effect via perforin-dependent
killing of activated T cells, although the specific receptors used to recognize target T cells and perforin-delivered
granzymes involved in triggering cell death remain incompletely defined. Whereas inhibition of perforin could
curtail NK cell-mediated immune suppression, this broad of an approach could temporarily undermine immunity
against pathogens and tumors, and thus a more refined approach targeting granzymes is proposed.
Therefore, the goal of this proposal is to advance an innovative high risk, high impact approach to foster HIV
vaccine efficacy through selective inhibition of granzymes involved in the immunosuppressive activity of NK cells.
Initial experiments in mice will use small molecule inhibitors and CRISPR to define the utility of targeting a specific
granzyme to limit NK-cell killing of T cells and suppression of vaccine-elicited adaptive immunity. Select inhibitors
will be validated in Rhesus macaques. Based on quantitatively defined go/no-go criteria establishing the success
of granzyme targeting to enhance vaccine efficacy, we will proceed to evaluation of this approach in vaccine-
mediated prevention of SIV infection in non-human primates. These experiments will also open impactful
avenues of investigation into the molecular features of both the immunosuppressive subset of NK cells and
targeted subpopulation of T cells. Thus, the proposed work will facilitate subsequent development and
deployment of innovative strategies to enhance HIV vaccine efficacy.

Public health relevance
PROJECT NARRATIVE HIV remains a global pandemic with no efficacious vaccine to prevent the millions of new infections that occur each year. This proposal explores an innovative mechanism for circumventing natural killer cell immunosuppressive activity, a roadblock to HIV vaccine success. The outcomes of this study will include advancement of an efficacious strategy for enabling vaccine-mediated induction of immune responses capable of preventing HIV infection.